NIGMS Equipment Supplement Program - 5 R01GM145790-02

PROJECT SUMMARY
Chronic inflammation and persistent infection conditions have long been associated with increased risk of cancer.
Growing evidence suggests that cancer-associated inflammatory processes, such as lipid peroxidation, cause
genomic instability that can be linked to the development of carcinogenesis. Reactive species from lipid
peroxidation are known to damage DNA and form etheno-type adducts. Previously, four etheno DNA adducts
have been reported: 1,N6-ethenoadenine (εA), 3,N4-ethenocytosine (εC), 1,N2-ethenoguanine (1,N2-εG), and
N2,3-ethenoguanine (N2,3-εG). These etheno lesions are also generated by metabolites of the human carcinogen
vinyl chloride. Recently, a new etheno adduct, 3,N4-etheno-5-methylcytosine (ε5mC), was identified. It bears the
etheno damage on 5-methylcytosine, an important epigenetic marker in humans. Thus far, no information on the
repair and mutagenicity of ε5mC has been reported. Replication of the etheno lesions is known to cause
mutations and may constitute a critical step in the pathway leading to neoplastic transformation. Importantly for
cells, DNA repair pathways are the guardians of genomic integrity and function to return damaged DNA to its
canonical state. This research project focuses on two key repair pathways: base excision repair (BER) and direct
reversal repair (DRR). Most of the experiments that give rise to our current understanding of BER and DRR were
conducted using DNA oligomers. There is a fundamental gap in knowledge of how repair occurs in the context
of chromatin, where eukaryotic DNA is compacted in a complex hierarchy of DNA-protein interactions. At the
most fundamental level of chromatin organization, the nucleosome core particle (NCP) is the basic packaging
unit that is comprised of ds-DNA wrapped around a histone protein core. The overarching goal of the proposed
research is to understand how DNA sequence context and the packaging of DNA into chromatin influence repair
of the etheno adductome. The central hypothesis of this proposal is that BER and DRR enzymes repair etheno
lesions with different efficiencies, and these distinctive repair profiles are the result of 1) sequence context of the
lesion and interactions with the enzyme and 2) modulation of repair by the protein component of chromatin, the
histones. Guided by this novel hypothesis, strong preliminary data, and innovative techniques, the proposal
investigates three aims that: (1) define the sequence context effects (by considering the 5’ and 3’ neighboring
bases) of BER and DRR enzymes in unpackaged DNA oligomers; (2) characterize the repair profiles of the five
etheno adducts in NCPs; and (3) determine the extent to which tailless and variant histone proteins provide a
mechanism of modulating repair in chromatin. The results obtained in this work will explain in vivo observations
of alkylation damage profiles and contribute to our understanding of mutational hotspots and mutational
signatures. Therefore, the research has considerable translational potential to enhance our understanding of
DNA repair and the results can assist in the development of future therapeutic treatments that improve cellular
defenses against genomic instability.

Public health relevance
PROJECT NARRATIVE Reactive species from lipid peroxidation generated under disease conditions damage DNA and form etheno lesions, which are strongly cytotoxic, mutagenic, and carcinogenic. This project will characterize the repair of these etheno adducts by enzymes across two distinct pathways: base excision repair and direct reversal repair. Results will identify the differential repair fingerprints of such lesions and inform future translational studies that capitalize on these repair mechanisms to protect against genomic instability.